Metal mixture effects on mitochondrial dysfunction in kidney development and maturation: Towards a whole mixture risk assessment

PROJECT SUMMARY
Nephrotoxic metal(loid)s including arsenic (As), cadmium (Cd), lead (Pb) and mercury (Hg) are established
kidney toxicants in humans and are each associated with chronic kidney disease (CKD). CKD affects 10-15% of
the global population and the prevalence is increasing alongside risk factors such as diabetes, hypertension and
obesity. Research conducted during perinatal developmental windows is a major gap in our understanding of
CKD etiology that is ethically and feasibly challenging in human populations. Further, a comprehensive
assessment of the effects of nephrotoxic metal mixtures (NMM) on kidney development and function remains
unknown, and fundamental gaps remain in how low-level early-life toxic exposures may alter kidney development
and maturation, initiating subclinical pathways to CKD. Perinatal life includes susceptible windows of kidney
development because life-stage-specific processes of metanephric branching, nephrogenesis, renal blood flow
regulation, and ion homeostatic processes are rapidly developing in comparison to the adult kidney. Small
alterations in bioenergetics due to NMM exposures at these life stages may set forth subtle changes in kidney
development or function that may not manifest clinically for years but can be detected and ameliorated if identified
early. Further, organismal and suborganismal responses predictive of nephrotoxicity provide mechanistic
information for formal risk assessment-based extrapolation to population-level effects. Our transdisciplinary
consortium efforts will enable risk assessment of real-life exposures to NMMs by harnessing: i) population-based
prenatal exposures to NMM from existing pregnancy cohorts and nationally-representative data among women
of reproductive age; ii) in vivo models (e.g. zebrafish, mouse) to determine the physiological impact and dose-
response of key affected pathways; iii) complementary assays in in vitro human kidney organoids to define
molecular mechanisms linking NMM exposure to adverse outcomes; and iv) experimental evidence of mixture
toxicity derived with population-relevant exposures to assess risks associated with the mixture using a ‘similar
mixture approach’ (SMACH) - a critical need valuable for risk assessors to derive regulatory guidance values
and improve public health. Moreover, the proposed studies address critical gaps in our understanding of how
NMM impact the developing kidney and will generate new findings on mechanisms as well as inform the early
life pathophysiology of adult CKD. This proposal leverages our team’s expertise in mixtures biostatistics and
epidemiology, risk assessment, metals nephrotoxicology, developmental biology, molecular renal physiology,
and bioengineering.

Public health relevance
PROJECT NARRATIVE Chronic kidney disease in adulthood originates in part from early life environmental exposures acting through critical windows of developmental susceptibility. Fundamental mechanistic nephrotoxicity information coupled with population-based risk assessment strategies are key to future interventions designed to prevent or treat later life chronic kidney disease. Together, the consortium will advance our understanding of the role of human- relevant metal mixtures in maladaptive kidney function using vertebrate and kidney organoid models and use experimental evidence to establish a population relevant whole-mixture risk assessment strategy applicable to diverse global populations.